Dr. Syed Nabeel Zafar’s application for the NCI Early-stage Surgeon Scientist Program (ESSP)

PROJECT SUMMARY
This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-
21-100. This career development proposal will provide Dr. Syed Nabeel Zafar, a surgical oncologist and expert
in gastrointestinal cancer, with the training and mentorship required to develop expertise in using data sciences
to improve the outcomes of patients undergoing surgery for pancreas cancer, with the goal of becoming a
successful independent surgeon scientist.
Pancreas cancer accounts for over 48,000 deaths per year in the US. Pancreas ductal adenocarcinoma (PDAC)
constitutes 90% of pancreas cancer, and while surgery with chemotherapy offers the best chance of long-term
survival, most patients have poor outcomes: over half survive less than 3 years from surgery, while only 20% of
patients live beyond 5 years. A critical barrier to improving survival is the inability to predict which patients will
follow favorable vs. unfavorable disease trajectories. This limitation has led to a one-size-fits-all approach for
patients with localized disease. To improve survival in patients undergoing surgery for PDAC, it is critical to
identify subsets who may benefit from personalized therapies. Prior prognostic research on PDAC has been
limited due to the lack of integrated datasets and limitations in analytic techniques. In this proposal, we will use
a novel multicenter electronic health record dataset of 64000 patients with pancreas cancer across 82 institutions
across the US. In Aim 1, we will derive, validate, and compare machine learning models to arrive at a highly
accurate prognostic model for overall survival after surgery for PDAC. In Aim 2, we will integrate genomic
information to further test and improve the accuracy of the model. Completion of this proposal will result in a
deeper insight into the factors associated with pancreas cancer survival, the identification of patient phenotypes,
digital biomarkers, or genomic mutations associated with poor prognosis, and a highly accurate prognostic
model. Such individualized prognostication will aid clinical decision making and precision medicine initiatives to
improve survival after resection for PDAC. Dr. Zafar will build upon his clinical and research background to
acquire new skills in survival analysis, machine learning, and genomic analysis that are crucial for his transition
to an independent surgeon scientist. Dr. Zafar is supported by an exceptional team of mentors, led by Dr.
Matthew Churpek who is world renowned for his work on using multicenter EHR data and machine learning to
build highly accurate predictive models to identify, risk stratify, and guide personalized care of patients with
critical illnesses. Dr. Mark Burkard is an expert in genomics and precision therapies; Dr. Sharon Weber, a
surgeon leader, senior pancreas surgeon, and section chief who will facilitate achievement of Dr. Zafar’s career
goals; and Dr. Ben Zarzaur, an independently funded surgeon scientist who will serve as a career mentor. This
award addresses a serious gap in PDAC research while affording the education and mentored research
experience critical for Dr. Zafar to develop an independent research program.

Public health relevance
PROJECT NARRATIVE Pancreas cancer accounts for over 48,000 deaths per year in the US and is projected to be the second leading cause of cancer deaths by 2030. Due to our lack of understanding of factors associated with survival, we are unable to identify subsets of patients that may benefit from individualized treatment and we therefore currently treat all patients with localized disease in the same way. As personalized therapy has immense potential to improve survival for pancreas cancer, this study will address limitations of prior research by integrating data from electronic health records and genomic information and will use advanced machine learning techniques to accurately identify subsets of patients that may benefit from personalized medicine initiatives.